Breast core-needle diagnostics in LMICs via millifluidics and direct-to-digital imaging: development and validation in Ghana

ABSTRACT
Breast cancer is an increasing challenge globally as it became the most prevalent malignancy at the end of
2020. More than 70% of all cancer mortality now occurs in low- and middle-income countries (LMICs).
Histology, critical to the diagnosis and disease management for many cancers notably including breast cancer,
is currently performed using techniques that are more than 100 years old. Market forces, technological
advances in optics, and innovation in care strategies are opening the door for disruptive innovation that could
massively reduce costs and time and improve accessibility while provide equivalent or even superior results.
We propose to contribute to the field's evolution by combining two already functioning and complementary
technologies: 1) a tissue millifluidics approach (developed in PI Seibel's lab) for hands-off core needle biopsy
handling; and 2) a rapid, low-cost, direct-to-digital slide-free imaging solution (developed in PI Levenson's lab).
The goal is to implement a context-appropriate, automated instrument that can capture diagnostic-quality
histopathology images from core-needle biopsies vital to high-quality breast-cancer diagnosis and staging, at
time of procedure. Additional project goals include implementation of innovative rapid immunofluorescence
methods for near-real-time therapy guidance; and development of AI tools for patient triage or even local
diagnostic support, the latter under the direction of Dr. Mahmood (BWH), a leader in multiclass AI algorithms.
Key to success of this project is local implementation and clinical evaluation in Kumasi, Ghana, under the
direction of Dr. Addai, consultant breast surgeon and CEO of Peace and Love Hospitals (established in 2002).
Her group will critically assess performance, usability, and compatibility with the service environment in both a
central hospital and a remote satellite clinic; clinical validation studies will eventually encompass at least
several hundred patients recruited under IRB-approved protocols. Additional guidance will be provided by Dr.
Dan Milner, CMO of the American Society for Clinical Pathology (ASCP), who has extensive experience in
global-health-focused initiatives, as well as by our collaborating pathologists who are familiar with issues
relevant to LMIC settings. Feedback will inform the design of the second-generation automated instruments to
be delivered near the end of this project.

Public health relevance
NARRATIVE The incidence of cancer and particularly that of breast cancer is rising in lower income countries; however, it is very difficult to provide diagnostic support to women with suspicious masses in resource-challenged areas. Obstacles include the absence of infrastructure needed to perform appropriate specimen histology as well as a lack of pathologists available to interpret the findings. In conjunction with a prominent breast-surgeon group in Ghana, we propose to develop an automated instrument into which needle biopsies of breast lesions can be introduced to immediately generate high-quality cellular-resolution images, including molecular phenotyping data, that can be used for diagnosis and treatment planning; the digital images can be interpreted locally, shared electronically, or even processed using artificial intelligence.